Implantable Self-Powered Biofeedback Vagus Nerve Stimulator for Weight Control

Project Summary
Recent breakthroughs in neuromodulation for diet and weight control have stimulated a growing interest in
the development of new anti-obesity strategies. However, achieving effective, real-time, and maintenance-free
electrical neuromodulation with minimal side effects remains a major challenge. To address this challenge, this
project proposes to develop a battery-free, flexible, and implantable piezoelectric nanogenerator (NG) that
produces closed-loop, biofeedback electrostimulation (ES) on the vagus nerves to control food intake
in response to stomach motions. This project builds on the collaborative work by Wang (PI) and Cai (co-I) of
an implantable vagus nerve stimulation (VNS) device, which achieved effective diet and weight control in rats.
The battery- and electronics-free VNS device is attached to the stomach surface and generates alternative
current (AC) ES signals to the vagus nerves only when the stomach moves upon food intake.
Our preliminary study demonstrated 38% less weight gain on normal adult rats with the VNS device
implantation as compared to controls over a 100-day testing period. Although this efficacy value surpassed most
peer reports, the ES signal intensity was 1-2 orders of magnitude smaller compared to those typically used. We
hypothesize that tuning the closed-loop ES signal to the typical level of neuromodulation may further increase
weight loss efficacy outperforming the currently-used non-natural continuous ES. To test this hypothesis and
eventually bring this intriguing technology to clinic, we propose to develop a piezoelectric NG that provides
tunable ES pulse signals up to 10 V in response to stomach peristalsis, and remains safe and stable over long-
term implantation. We will also optimize the implantation of the VNS device and validate the closed-loop VNS
efficacy and advantages to using standard obese rat models. In Specific Aim 1, we will develop a biomaterial-
based flexible piezoelectric NGs that can produce tunable ES pulses in response to simulated stomach
movements. In Specific Aim 2, we will evaluate the biocompatibility of the NG ex vivo and in vivo on the stomach
of rats, and examine implantation sites and in vivo outputs in correlation to stomach motions. In Specific Aim 3,
we will quantify and compare the diet and weight control performances on two obese rat models among three
different strategies of using on-stomach NGs for VNS: (1) battery-powered open-loop VNS; (2) NG-enabled self-
powered closed-loop VNS; (3) NG-switched battery-powered closed-loop VNS.
This project will deliver a novel biomaterial-based VNS device that is battery- and electronics-free for weight
control. This project uses rat model to test the new VNS devices, providing rapid feedback for device optimization,
and quantifying the therapeutic efficacy in correlation to ES signals. Implantation-related technical issues will
also be addressed. Together, we will establish an essential biological and engineering foundation that will allow
us to move rapidly to the next step of in vivo studies in large animal models, eventually leading to human trials.

Public health relevance
Project Narrative This project proposes to develop a battery-free, flexible, and implantable piezoelectric nanogenerator device that performs closed-loop biofeedback electrostimulation (ES) on the vagus nerves to control food intake. This device is attached on the stomach surface and generates tunable ES signals in response to stomach peristalsis upon food intake. This project will establish an essential biological and engineering foundation that will allow us to move rapidly to the next step of in vivo studies using this closed-loop neuromodulation technique in large animal models, eventually leading to human trials.